Evaluation of novel microscale cell culture platform for translational drug development in prostate cancer

Prostate cancer is a disease with a remarkably high impact on Veteran health. Not only is it the
most common cancer diagnosed in Veterans, with nearly 15,000 new cases diagnosed each year,
but Veteran men get diagnosed with prostate cancer at nearly twice the rate of the general
population 1. Unfortunately, even with treatment, many of these Veterans will ultimately die from
their disease. New, effective treatments are therefore desperately needed to improve outcomes
for Veterans with prostate cancer. Although the development of new prostate cancer research is
currently under way, the development of such therapies is heavily limited by current preclinical
research models, which do a notoriously poor job of identifying therapies that will be effective at
the clinical level. We have therefore developed a novel open microfluidic cell culture platform that
enables multi-culture tumor models in vitro using primary, patient-derived cells. The central
hypothesis in this proposal is that primary cell derived multi-culture TME models in Stacks will
more closely model patient tumor biology and can better predict clinical therapeutic efficacy in
prostate cancer than traditional preclinical models. The primary objective of this proposal will be
to test this hypothesis through three Specific Aims: Aim 1: To determine whether the gene
expression profiles of prostate tumor cells in multi-culture Stacks models more closely
correlate with patient expression profiles than tumor cells in traditional in vitro models.
Tumor cells (cell line and patient-derived organoids) will be cultured in traditional in vitro platforms
in mono-culture and in co-culture with primary macrophages/cancer-associated fibroblasts. The
same mono- and co-culture models will also be established in Stacks along with the addition of a
tri-culture model with all 3 cell populations. RNA-seq will then be performed on the tumor cells
from each model. Transcription profiles will be compared to patient datasets to determine which
model most closely correlates with patient tumors. Aim 2: To establish whether multi-culture
tumor models in Stacks can more accurately predict the efficacy of therapies in patients
with prostate cancer than standard in vitro models. Using the same models in Aim 1, each
model will be treated with 3 therapies known to be effective in patients with prostate cancer and
3 therapies known to be ineffective in patients with prostate cancer. The cytotoxic effect of the
therapies will be evaluated in each model and compared to clinical trial data to determine which
system most accurately predicts therapeutic efficacy at the clinical level. Aim 3: To evaluate
whether patient-derived TME models in Stacks can predict therapeutic response to
docetaxel in Veterans with prostate cancer. Co-culture models will be established in Stacks
using tumor cell lines and primary monocyte-derived macrophages from Veterans with prostate
cancer about to initiate docetaxel treatment. Stacks models will then be treated with docetaxel
and evaluated for the cytotoxic effect of the treatment. The data from each patient-derived Stacks
model will then be compared to the docetaxel response in the corresponding patient to determine
if the Stacks co-culture models can predict therapeutic response in patients. The data from each
of the Aims will be analyzed to determine if multi-culture models are more biologically and clinically
relevant and if the Stacks platform is a more effective tool than traditional in vitro platforms for
translational prostate cancer research.

Public health relevance
Prostate cancer is a disease with a remarkably high impact on Veteran health. Not only is it the most common cancer diagnosed in Veterans, with nearly 15,000 new cases diagnosed each year, but Veteran men get diagnosed with prostate cancer at nearly twice the rate of the general population. Unfortunately, even with treatment, many of these Veterans will eventually die from their prostate cancer. New, effective prostate cancer treatments are therefore desperately needed. While this research begins in the lab, current laboratory research models do a notoriously poor job of identifying therapies that will be effective in patients. We have therefore developed a new cell culture platform, called Stacks, that enables improved modeling of patient tumors in the lab using their own cells. Our primary objective in the proposal will be to determine whether the Stacks platform can better mirror the biology inside patient tumors and more accurately predict the effectiveness of prostate cancer therapies in Veteran men with metastatic prostate cancer than currently available platforms.